Hox gene regulation of body size and asexual reproduction underlie regenerative abilities

Abstract
The ability of certain animals to regenerate their cells and tissues has long been a subject of interest for
biologists due to its relevance to animal development and regenerative medicine. However, we still don't fully
understand why some animals regenerate so well, while others cannot. From a holistic perspective, the loss of
regenerative capacity in vertebrates correlates with the evolution of larger and more complex body plans as well
as the loss of asexual reproduction. However, it's unclear how body size or anatomical complexity affects
regenerative processes, and the role of asexual reproduction in this process is unknown. This knowledge gap
centers on a fundamental principle underlying the differential regenerative properties of animals and their tissues.
Hox genes are conserved transcriptional regulators key to the evolutionary diversification of body plans.
Although Hox genes have been extensively studied in animals with limited regenerative capabilities, their
functions in animals capable of whole-body regeneration are not well understood. A better understanding of Hox
gene functions in highly regenerative organisms could provide valuable insight into the body plan features that
underlie the retention and modification of regenerative abilities.
As a trainee, I have discovered that Hox genes regulate asexual reproduction in planaria, a flatworm that
can regenerate its entire body. This invertebrate model's potent regenerative abilities and amenability to
advanced molecular analysis and large-scale gene interference screens make it ideal for studying the
fundamental mechanisms of animal regeneration. Our recent preliminary data reveal a new role of Hox genes in
limiting the body size of planarians. Taking advantage of this finding, we generated animals five times their
normal size and discovered that planarian regenerative abilities cannot functionally scale in an expanded body
plan. Finally, we have identified genes with dual functions in both whole-body regeneration and asexual
reproduction from a large RNAi screen of transcriptional regulators, which lays the foundation for uncovering a
shared gene regulatory network linking these processes.
Through the mechanistic dissection of how Hox genes support planarian whole-body regeneration, I aim
to expand our understanding of the functions of these key developmental genes while providing important insight
into the fundamental principles distinguishing regenerative versus non-regenerative body plans. This work has
the potential to enhance our understanding of the permissive factors underlying tissue regeneration and to inspire
and inform novel approaches to improving human health.

Public health relevance
PROJECT NARRATIVE My research focuses on understanding the underlying principles and mechanisms that enable an animal's body plan to regenerate, using the experimentally tractable research model planaria. Through my recent work, I have discovered that Hox genes play a crucial role in restricting body size and facilitating asexual reproduction, both of which are functionally linked with the planarian's impressive regenerative abilities. My lab is now poised to delve deeper into the molecular mechanisms behind how Hox genes regulate body size, how that size regulation facilitates regenerative processes, and how Hox functions in asexual reproduction are molecularly intertwined with the ability to regenerate the entire body.